Investigating the RNA-Regulatory Activities of the RNA Exosome during Human Motor Neuron Differentiation

Project Summary:
Accurate stem cell differentiation requires precise gene regulation at both the transcriptional and post-
transcriptional levels. While the transcriptional activation networks governing cellular differentiation are well
characterized, the mechanisms by which post-transcriptional control of gene expression alters the transcriptome
to confer cellular identity remain poorly understood. The RNA exosome, an essential and ubiquitous post-
transcriptional ribonuclease complex, plays a significant role in cellular differentiation by modulating steady-state
level of RNA to maintain the pluripotent potential of stem cell and progenitor populations. Depletion of a single
RNA exosome subunit results in precocious differentiation in several cell types, and deletion of any subunit is
embryonically lethal. Although the RNA exosome is conserved from yeast to humans and plays essential roles
in all cells, recessive mutations in RNA exosome subunit genes disproportionately affect neuronal tissues and
give rise to severe neurodevelopmental disorders (NDDs). For instance, mutations in the EXOSC3 gene,
encoding a structural cap subunit of the RNA exosome, cause Pontocerebellar Hypoplasia Type 1b (PCH1b), a
prenatal onset NDD associated with severe spinal motor neuron defects that emerge during embryonic
development. Similarly, a mutation in the EXOSC4 gene, which encodes a core subunit of the RNA exosome,
was recently linked to a distinct NDD with a comparable spinal motor neuropathy phenotype. These findings
suggest that spinal motor neurons are uniquely susceptible to RNA exosome-mediated post-transcriptional
regulation defects. However, the RNA exosome has not been studied in human neurons or during neuronal
differentiation. To investigate the function of the RNA exosome during neuronal differentiation, I will utilize human
induced pluripotent stem cells (hiPSCs), engineered by my lab via CRISPR technology, to model RNA exosome-
linked motor neuron diseases, including severe PCH1b (EXOSC3-G31A), mild PCH1b (EXOSC3-G191C), and
a novel NDD linked to a mutation in EXOSC4 (EXOSC4-L187P). To study the RNA exosome in a disease-
relevant context, I will investigate the impact of pathogenic EXOSC3/4 mutations on human spinal motor neuron
differentiation using a 2D cell culture method. I hypothesize that disease-linked mutations in EXOSC3/4 alter
the function of the RNA exosome during motor neuron differentiation, leading to an accumulation of pathogenic
RNA species that cause spinal motor neuropathy. This research will provide a comprehensive analysis of how
pathogenic mutations in RNA exosome subunit genes impact post-transcriptional regulation during human
neuronal differentiation and provide insight into pathological mechanisms underlying RNA-mediated motor
neuropathy.

Public health relevance
Project Narrative: The RNA exosome is a ubiquitously expressed RNA-regulatory complex essential for cellular differentiation in humans. Inherited mutations in RNA exosome subunit genes cause devastating neurodevelopmental diseases, several of which cause severe motor neuron defects. To investigate the role of the RNA exosome in neurodevelopment, we will use human motor neurons modeling disease-causing RNA exosome mutations in vitro to assess the role of the complex during motor neuron development and provide insight into RNA exosome- linked motor neuropathy.